EFFECT OF EXERCISE ON PROTEIN TURNOVER IN OLDER WOMEN

Preliminary data of other investigators looking at protein turnover in women have shown an increase in rates of both protein synthesis and degradation with increased age when adjusted for differences in body cell mass. The same group of investigators have examined the protein requirements of a few elderly men and women using nitrogen balance techniques in a metabolic unit environment had have found that the elderly women studied had a two-fold increase in estimated protein requirements compared to that found for the elderly men studied. Requirements for the elderly women were also increased compared to that obtained in other studies of young women. This could mean that sex-specific and age specific differences in metabolism of protein exist in addition to those attributable to body compositional differences. One possible reason for the increased protein requirement seen in elderly women could be the decreased amount of lean body mass, and more specifically, muscle mass, seen with age. The effect of this decreased body compartment on protein utilization may be negative, in that the efficiency of using dietary protein may be decreased with a decreased compartment. It has been shown that intensive exercise increases protein turnover, resulting in increased protein breakdown during the period of exercise. This has been observed in young subjects. Whether this also occurs in elderly subjects, and whether endurance training will reverse some of the changes in protein turnover and utilization, is the main objective of the proposed study. Through gaining additional knowledge of protein metabolism in the elderly woman, more specific recommendations regarding adequacy of protein in the diet of this population group can be made, as can recommendations regarding the required level of activity compatible with maintaining good health status. This is particularly relevant due to dietary data which indicates that a substantial percentage of elderly participating in national surveys consume less than the Recommended Dietary Allowances, which have been shown to be inadequate levels of intake for elderly women. The proposed study will evaluate protein utilization in two groups of women: aged 20-25 and 60-65, and determine the effect of a 12 week period of endurance training exercise. Protein utilization will be evaluated by using 15-N-glycine and short term nitrogen balance studies before and after the 12 week training period.